Training in Comparative Lung Biology and Medicine

PROJECT SUMMARY / ABSTRACT
This is a revised, competing renewal application for a highly successful Center of Comparative
Respiratory Biology and Medicine (CCRBM) T32 program that has trained more than 120 pre-
doctoral students and post-doctoral scholars in lung biology and medicine over the last 39 years.
The objective of this pre- and post-doctoral program is to train the next generation of scientists
through interdisciplinary research and coursework that addresses issues of direct relevance to the
NHLBI mission. We are requesting (annually) funds for two years of support for each of 6 pre-doctoral
and 3 post-doctoral trainees recruited from several UC Davis graduate programs and departments
that provide disciplinary training relevant to lung health, including pharmacology, toxicology, cell
and molecular biology, informatics, engineering, epidemiology, immunology and genetics. Training
faculty- 35 active researchers from 12 departments- have substantial experience mentoring
students. Faculty preceptors will direct research training in four primary areas: 1) Lung Immunology
and the Airway Epithelium 2) Engineering and Informatics in Lung Medicine; 3) Lung Health and
the Environment; 4) Translational Research and Therapeutics. Significant interactions among our
training faculty members promote interdisciplinary approaches to lung research. Trainees have
access to advanced technologies, such as proteomics, epi/genomics, breath metabolomics, state-
of-the-art imaging, genetically modified organisms, and inhalation facilities for rodents and non-
human primates. Molecular, cellular, tissue, and diverse animal models, including nonhuman
primate models, complement human studies from faculty in the Division of Pulmonary, Critical Care,
and Sleep Medicine and the Center for Comparative Respiratory Biology and Medicine. The training
program leverages the activities and resources of multiple research centers at UC Davis to provide
synergy and promote connections to disease prevention and public health; examples include the
Clinical and Translational Science Center, the Environmental Health Sciences Center at UC Davis,
the NCI Comprehensive Cancer Center, the California National Primate Research Center, the NIH
Mouse biology program, the Genome Center, and the NIH-designated West Coast Metabolomics
Center. The training program also emphasizes practical instruction in scientific writing and
communication of scientific findings to peers and lay audiences through chalk talks, town halls, and
national meetings. Trainees are exposed to emerging concepts, controversies, and technologies in
lung health by participating in the program’s research and training conferences including the weekly
CCRBM seminar series, other specialized seminar series, and the annual “Lung Day” retreat.

Public health relevance
PROJECT NARRATIVE The Training in Comparative Respiratory Biology and Medicine Program at UC Davis provides unique training in lung biology to pre-doctoral students and post-doctoral scholars to prepare them for diverse research careers focused on lung health. This program builds on existing interdisciplinary and collaborative research strengths at UC Davis, with integration of studies at the molecular, cellular, organismal, and human levels to better understand lung disease and improve treatments. Funds are requested to provide two years of support a total of nine pre- and post-doctoral trainees who will receive a combination of didactic and experiential training in current and emerging concepts in lung health.